Post-translational Modification of Cx43 Regulates Myometrial Quiescence

PROJECT SUMMARY ABSTRACT
Women of color are underrepresented in biomedical research and this Diversity Supplement is submitted to
mentor Mariani Ramirez to earn a PhD as a pharmacologist. Her project is to look for ways to prevent preterm
birth, a major medical problem resulting in disability and death for very preterm infants. Therapeutic approaches
to manage preterm labor are off-label and ineffective. No tocolytic therapy in use today is satisfactory beyond 48
hours, and none are FDA approved. Preterm labor more often impacts African American women than their
Caucasian counterparts. We seek to understand the dysfunctional relaxation of the myometrium that leads to
preterm labor and resulting preterm birth. Our central hypothesis is that nitric oxide is generated locally within
the myometrium by microvascular endothelial cells as a result of mechanical stretch and increased blood flow to
the expanding uterus. Nitric oxide S-nitrosates Cx43 in the muscle cell. Cx43 S-nitrosation promotes C-terminal
phosphorylation that holds Cx43 in its hemichannel state and favors muscle cell quiescence. Hemichannels form
gap junctions at the time of labor. Gap junctions are a feature of activated myometrium. Promoting connexin 43
S-nitrosation offers a unique target for tocolytic development. Translational approaches in human pregnancy
tissues are essential if we are to discover and exploit the unique mechanisms that subserve uterine quiescence
during pregnancy and their dysregulation in preterm labor.

Public health relevance
PROJECT NARRITIVE Preterm labor leads to preterm delivery of an underdeveloped fetus in 50% of cases and there are no FDA- approved medications available to prevent preterm delivery. The research planned in this application will employ tissues and cells from pregnant women. Mariani Ramirez is a diversity applicant whom we will mentor to examine the role of endogenous nitric oxide, which relaxes the muscle of the term, but not preterm human uterus, in regulating the formation of gap junctions that couple the tissue electrically and coordinate labor contractions.